Social Media Action to Reach, Teach and Educate Greater Richmond, VA, 2.0 (SMARTER-VA 2.0)

OVERALL: PROJECT SUMMARY
The Massey Cancer Center (MCC) at the Virginia Commonwealth University (VCU) seeks the renewal of its
National Cancer Institute (NCI) Cancer Center Support Grant (CCSG), an award it has continuously held since
1975. As a leading academic medical center within the Commonwealth of Virginia, the MCC serves a 66-locality
catchment area spanning central, southern, and eastern Virginia. This region is home to more than four million
residents and is characterized by communities with substantial racial, geographic, and socioeconomic diversity
that contributes to a higher overall cancer burden and significant health disparities than reported nationally. The
MCC is home to an interdisciplinary cohort of 147 cancer investigators from six VCU Schools and Colleges.
These investigators are organized into three, highly productive research programs – Cancer Biology,
Developmental Therapeutics, and Cancer Prevention and Control. To provide these cancer scientists with
access to the latest technologies and highest-quality methodologies, MCC requests CCSG support for six shared
resources: Biostatistics, Flow Cytometry, Lipidomics and Metabolomics, Microscopy, Tissue and Data
Acquisition and Analysis, and Transgenic/Knockout Mouse. As part of its overall organizational strategy, the
MCC also provides its membership direct supportive services through an Office of Cancer Research Training
and Education Coordination; Office of Community Outreach and Engagement; Office of Diversity, Equity, and
Inclusion; Office of Research Development within the MCC Administrative Core; and a centralized, full-service
Clinical Trials Office (CTO). Of note, the MCC is one of 14 Minority/Underserved NCI Community Oncology
Research Programs in the US charged to facilitate access to and implementation of clinical research throughout
its catchment area in partnership with 11 community-based cancer practices. The MCC has invested $33.4M
since its last competing renewal in 2016, in the strategic recruitment of a diverse group of 38 cancer scientists
to VCU. Other evidence of MCC’s success includes marked positive trajectories of growth – since 2016 a 32%
increase in annual direct NCI research funding, 70% increase in the number of collaborative team science
awards, and with notable increases in the percentages of racial/ethnic underrepresented minority senior
leadership (11% to 45%) and membership (6% to 12%). Further, MCC members reported their research
discoveries and outcomes in 990 peer-reviewed publications with 43% reflecting inter- and/or intra-programmatic
collaborations. After significant health system investments in a new electronic medical record system and a CTO
restructuring, there has been a 51% growth in interventional trial accruals since 2019. Guided by the 2021-2025
Strategic Plan, MCC’s overarching focus for research, education, and community outreach and engagement
efforts will be to reduce cancer health disparities and improve survivorship for all with priorities placed in
developing innovative approaches to the prevention and treatment of lung, gastrointestinal, breast, and prostate
cancers as well as two key behavioral factors, tobacco and obesity control.

Public health relevance
OVERALL: PROJECT NARRATIVE The mission of the Massey Cancer Center (MCC) is to reduce the state cancer burden for all Virginians by addressing the confluence between biological, social, and policy drivers through high-impact, cutting-edge research; person-centered care across the continuum, from prevention through survivorship; community integration; and training the next generation of community-centric researchers and healthcare professionals. The core of this mission has been supported by the National Cancer Institute’s Cancer Center Support Grant (CCSG) since 1975, and the MCC is seeking renewal of this award for another five years. The CCSG supports efforts across the MCC senior and programmatic leadership; administration; community outreach and engagement; cancer research training and education coordination; promotion of center-wide diversity, equity, and inclusion; shared resource support and management; clinical research infrastructure; and developmental funding to supporting team-based, transdisciplinary research strategies focused on well-defined, catchment area priorities.